2/2 A Phase 2 Study of Elafin (Tiprelestat) for the Treatment of Pulmonary Arterial Hypertension (PAH)

PROJECT ABSTRACT
The ATHENA trial represents a new paradigm to slowing the progression of disease in people with pulmonary
arterial hypertension (PAH). With our clinical coordinating center (CCC) collaborators, we propose a phase 2,
multi-center, randomized, double-blind, placebo-controlled trial of tiprelestat (recombinant human Elafin) to
evaluate its impact on pulmonary vascular resistance (PVR) and safety. Participants will be stratified by baseline
PVR and baseline REVEAL Lite 2.0 risk score. The primary endpoint of the study is the change in PVR from
baseline to week 24. Our clinical collaborators have successfully demonstrated the safety and tolerability of
Elafin in a phase 1 trial of 30 healthy individuals (NCT 03522935), and have assembled a group of clinical sites
with experience in PAH and clinical trials. The ATHENA trial will extend their promising pilot data to a formal
phase 2 clinical trial among PAH patients.
An experienced data coordinating center (DCC) with strong statistical leadership and expertise is key in both
design and analysis, particularly when unanticipated issues arise during the conduct of a clinical trial. The
University of Michigan (UM) Statistical Analysis of Biomedical and Educational Research (SABER) unit within a
top-ranked department of biostatistics will serve as DCC, bringing together an experienced group of faculty and
staff in biostatistics, project management, study monitoring, database design and data management, software
development, and research administration. SABER has a strong track record of collaborations with a CCC under
this funding model. The overarching goal of the UM DCC is to collaborate with study investigators, the CCC, and
NHLBI to enable successful achievement of the study on time and within budget. We will accomplish these goals
through the three specific aims: (1) Enhance scientific rigor by providing statistical and clinical trials
methodological expertise to design, analyze, and disseminate research findings; (2) Ensure the collection of
timely, accurate and reproducible data, and maximize adherence to the study protocol; and (3) Provide
established infrastructure and services for study administration and operations and for communication among
study stakeholders. Our leadership, experience, and expertise will promote collaborations, encourage scientific
productivity, and facilitate timely dissemination of findings on the benefits of Elafin in patients living with PAH.
We anticipate that upon completion of this proposed study, our data will support the role of Elafin as a safe and
efficacious PAH therapy, with the potential to be a disease-modifying agent with therapeutic effects sustained
even after the treatment is discontinued. It will inform the design of the Phase 3 pivotal study of this novel PAH
therapy.

Public health relevance
PROJECT NARRATIVE Despite therapeutic advances during the last two decades, pulmonary arterial hypertension (PAH) remains an incurable disease. In this proposal, we evaluate the efficacy, safety and tolerability of human recombinant Elafin as a transformative disease-modifying therapy, because of its many functions aimed at reversing the pathological processes of PAH that cause obliteration of lung blood vessels.